A Therapeutic Role for Apolipoprotein-E in the Germ Theory of Alzheimer's Dementia

Abstract: A Therapeutic Role for Apolipoprotein-E in the Germ Theory of AD
P. gingivalis is the keystone bacteria of periodontal disease, the 6th most common infectious disease
worldwide. Half of all Americans over the age of 30 and 70% of those over age 65 suffer some degree of P.
gingivalis infection associated with gum disease. In a study of 6800 patients with gum disease that were
followed for up to 26 years, those that developed gingivitis and then periodontal disease were linked to a
significantly increased risk of dementia including Alzheimer's dementia. Tooth loss, a frequent outcome of
periodontal disease, was also associated with an increased the risk of dementia. P. gingivalis products
including lipopolysaccharide, cysteine proteases known as gingipains, and 16S rRNA from P. gingivalis have
all been found in the brains of Alzheimer's patients. Since P. gingivalis is found in the mouth, the blood and is
known to invade non-oral tissues including the brain, then strategies to reduce P. gingivalis numbers and
activities including reducing brain inflammation, are beginning to show positive effects on outcomes associated
with AD in animal models and in the clinic.
We recently discovered that small mimetics of Apolipoprotein-E (ApoE-mimetics) inhibited the growth
and killed P. gingivalis bacteria. Other groups have reported similar anti-bacterial activities of ApoE-mimetics
including our ApoE-mimetics. These anti-bacterial activities appear to correlate with anti-inflammatory
activities of ApoE-mimetics reported by us and other groups. We reported that these ApoE-mimetics extended
lifespan in mice subjected to whole body sepsis using a caecal ligation and puncture model. We also reported
that these ApoE-mimetics cross the blood brain barrier where they reduce brain inflammation in multiple
models of Alzheimer's disease.
In this grant, we propose to preferentially kill P. gingivalis by a unique strategy. This strategy involves a
targeting ligand that specifically binds to a unique cell surface protein on P. gingivalis that, when conjugated
with our anti-bacterial ApoE-mimetics, provides a “targeted” anti-bacterial agent. We refer to the “P. gingivalis
targeting motif” as a “gingi-tif” and the conjugation with an ApoE-mimetic with as an “ApoE-gingitif”. As proof-
of-principle, we now show that the ApoE-gingitif known as RGN2002 retains bacterial killing activity and
preferentially targets P. gingivalis killing over killing of commensal bacteria (Figure 9 and Table 2). We will
synthesize additional ApoE-gingitif and gingitif-ApoE conjugates and use them to measure the minimum
inhibitory concentrations (MICs) against P. gingivalis. We will also use these ApoE-gingitif and gingitif-ApoE
conjugates to measure MICs against a non-pathogenic commensal bacteria also found in the mouth. The ratio
of the MICs for killing pathogenic P. gingivalis versus non-pathogenic commensal bacteria will provide a
quantitation of the preferential killing of P. gingivalis, which we call a “Preference Ratio.” (Table 2). Once our in
vitro screen has selected an appropriate ApoE-gingitif or gingitif-ApoE conjugate, then we will test these
conjugates in a whole mouse model of P. gingivalis infection. Since oral delivery of P. gingivalis resulted in
increased amyloid beta peptide 1-42, increased phosphorylated-tau and increased cytokines, which are all
found in Alzheimer's patient's brains, we will measure these products in the brains of P. gingivalis infected
mice with and without ApoE-gingitif or gingitif-ApoE conjugate treatment. These results will permit us to
determine the efficacy of this targeted “ApoE-gingitif-strategy” to reduce brain inflammation and pathology
associated with AD and P. gingivalis infections.

Public health relevance
Narrative: A Therapeutic Role for Apolipoprotein-E in the Germ Theory of AD The bacteria responsible for periodontal disease in the mouth has been found in the brains of many Alzheimer's patients. We have developed a novel strategy to target these pathogenic bacteria and preferentially kill them. By reducing the numbers of these bacteria and the inflammation that they cause in the brain, we anticipate improvements in Alzheimer's symptoms that will be measured.